Core 1: Mouse and Cell Modeling

PROJECT SUMMARY (Core-1)
Genetically engineered cell lines and mouse models are critical for elucidating complex biological processes.
The ability to customize the context in which these scientific questions are asked is at an unprecedented level
of detail and technical precision. Essentially, any genetic target can be altered to address protein localization,
protein-protein interaction or structure-function relationships at endogenous levels of expression and
regulation. The Mouse and Cell Modeling Core (Core 1) will create new research materials for the P01 projects
and repurpose multiple, established mouse models to generate novel reagents in the way of primary cell lines.
With CRISPR/Cas9-based gene editing tools, Core 1 will modify human cell lines to enable the dissection of
the BRCA network as described in the individual P01 projects. Key genes will be disrupted in breast cancer
and medulloblastoma cell lines and proteins involved in DNA repair and replication stress relief will be modified
to disrupt their interaction domains. This comprehensive approach among the investigators will allow exchange
of results related to each the projects and inform future directions. Mouse embryonic fibroblasts (MEFs) and
embryonic stem (ES) cell lines will be generated to study protein localization to sites of DNA damage and
repair efficiency in near wild-type backgrounds, except for the desired mutations. In producing the desired
MEFs, genetically matched controls will be produced concomitantly. Commonly used cell lines may have
uncharacterized defects in DNA repair pathways, while newly generated MEFs and ES cells are near native
state. A unique mouse model will be made by adding to an existing Brca1/Trp53 conditional line a null allele for
a strong predicator of chemoresistance. As Brca1, Trp53 and the new target are all located on the same
chromosome, CRISPR/Cas9 will be used in embryos derived by in vitro fertilization (IVF) to disrupt the gene
without having to do extensive interbreeding to combine the three physically close alleles. Another unique
mouse model will be made by deleting the genomic sequence in Brca1 that encodes the binding region of key
interaction partner. Core 1 draws on expertise in mouse embryo handling, mouse embryonic fibroblast and
embryonic stem cell production, cell line gene editing, evaluation of cell line knock-outs, mouse model creation,
CRISPR/Cas9 project design, complex project management and efficient breeding of existing mouse lines. By
concentrating production of gene edited cell lines in Core 1, research in individual laboratories can be focused
on downstream analyses.

Public health relevance
PROJECT NARRATIVE (Core-1) The interconnectedness of the projects requires a Core structure to generate the unique set of research tools for the successful and timely execution of the P01 projects. By supporting all of the individual projects of the P01, Core 1 will help advance understanding of the mechanisms of the BRCA network in cancer development and therapy response, which will facilitate rationally designed strategies for cancer prevention and treatment.